Improving Technology Innovation in Medicaid Programs

Project Abstract Improving Technology Innovation in Medicaid Programs Health technology innovations have the potential to improve patient outcomes and deliver cost savings, but these benefits have not been realized by Medicaid programs. Even when high-tech treatments are available, Medicaid patients may be less likely to receive treatment and have worse health outcomes. Other forms of technology innovations, including web-based platforms and applications, are also under- evaluated and implementation lags behind user needs. The identification of pain-points and areas of improvement are necessary for designing research and investment systems that can take advantage of health-technology for Medicaid beneficiaries. A convening of states’ Medicaid Medical Directors would provide the unique opportunity to understand undiscovered challenges facing Medicaid consumers and Medicaid programs at large that may be amenable to improvement through technology innovation. The 2021 “Workshop to Inform Technology Innovation and Research for Medicaid Programs” will utilize the Design Thinking Process to guide clinician leaders through a shared discovery and understanding of the needs of Medicaid beneficiaries and they will ideate prototypes of solution to address beneficiary needs. Baseline information about technology-amenable challenges faced by Medicaid beneficiaries will be collected through pre-workshop surveys. Building on the pre-workshop activities, the workshop organizers will guide participants during the first phase of the workshop to brainstorm and identify areas of promise to pursue. The second phase of the workshop will iteratively enable clinician leaders to ideate prototype solutions. Post-workshop activities will organize, synthesize, codify, and disseminate the workshop findings so that that policy, research, and innovation ecosystems can prioritize their activities to improve Medicaid beneficiaries lives through innovative use of technology.

Public health relevance
Project Narrative Improving Technology Innovation in Medicaid Programs With support from AHRQ, AcademyHealth developed the MMDN to assist clinical leaders of state Medicaid programs with identifying and applying the latest research findings and related information to address high priority policy and program issues, especially related to quality assurance, quality improvement, and coverage decisions. Aligned with the mission of AHRQ, the purpose of the 2021 “Workshop to Inform Technology Innovation and Research for Medicaid Programs” is to promote a research and innovation agenda that makes access to health-technology more equitable and affordable. AcademyHealth’s Evidence-Informed State Health Policy Institute (ESHPI) has a long history of convening the Medicaid Medical Director’s Network (MMDN) and in collaboration with Social Innovation Ventures, this workshop will provide a unique and timely opportunity to gather clinician thought leaders and Medicaid program designers to accelerate the application of evidence-based care and expand research agendas to include evaluation of existing technologies.